High-Intensity Ultrasound Ablation for Septal Reduction Therapy of Hypertrophic Cardiomyopathy

PROJECT SUMMARY
Obstructive hypertrophic cardiomyopathy (HCM) causes significant symptoms and morbidity due to left
ventricular outflow tract obstruction (LVOTO). Interventricular septal (IVS) reduction procedures for LVOTO
such as alcohol septal ablation and surgical myectomy relieve symptoms and reduce sudden death risk, but
are often initiated late in the disease process due to their peri-operative risk, anatomic constrains,
complications (particularly atrio-ventricular (AV) block) and limited efficacy. Our laboratory has developed an
attractive approach to IVS reduction therapy (SRT) and obtained preliminary large animal data using a high-
intensity ultrasound (HIU) catheter system for the treatment of oHCM, severe LVOTO and its consequences.
HIU has distinct benefits over existing SRT methods in that it:
1) is less invasive (delivered via a femoral venous approach to the right ventricle (RV)).
2) selectively ablates the mid-myocardium while sparing the sub-endocardium (which contains the His-
Purkinje system), thereby reducing risk of AV block.
3) does not rely on unpredictable anatomic availability of septal perforator coronary artery branches.
This proposal will further develop HIU IVS reduction by optimizing lesion size and depth, avoiding the
near-field subendocardium, tracking catheter location/orientation/contact, confirming effective formation non-
invasively, and initiating regulatory work to position us for first-in-human studies with a subsequent award. In
Aim 1, we will use acoustic simulations to design, fabricate and validate optimal HIU transducers and catheters
in ex-vivo models. Aim 2 will develop and test several advanced catheter design features that will confirm
transducer-tissue contact, track catheter location in real time, and confirm effective IVS ablation after HIU
sonication is performed. Aim 3 will study fully-developed HIU catheters in-vivo to determine ability to reduce
IVS thickness (and local myocardial mechanics) over 30 day survival.
The assembled team includes exerts in therapeutic ultrasound, acoustic physics, echocardiography,
cardiac MRI, large animal research methods, research sonographer, and an HCM clinical researcher who will
help with eventual translation of this work to first-in-man studies. Regulatory consultants will ensure that animal
studies are performed in a Good Labor and Practices (GLP)-compliant manner, positioning our group for an
Investigational Device Exemption for an Early Feasibility Study with subsequent awards.

Public health relevance
Project Narrative The objective of this project is to develop a catheter ablation system that uses high-intensity ultrasound energy to selectively ablate the mid-interventricular septum of the heart, as a potential treatment for obstructive hypertrophic cardiomyopathy (HCM). This device and approach has several advantages over existing septal reduction therapies for HCM in that it is less invasive, independent of variabilities in patient anatomy, and may spare the His-Purkinje system resulting in a lower incidence of atrio-ventricular block and pacemaker implantation. Incorporation of cardiac imaging features into the catheter to both track its location as well as to confirm creation of durable lesions will improve both safety and efficacy of the procedure.